Microtubule motors, cytoskeletal organization and cell polarity

PROJECT SUMMARY
The overall goal of our work is to understand how microtubules and microtubule motors define
the structure of cytoplasm and interphase cell polarization. We and others have established, that
in addition to the “canonical” function of moving cargo along microtubules, kinesin-1 and
cytoplasmic dynein can move cytoskeletal filaments themselves thus organizing the cytoplasm
and polarizing cells. We will use three biological models in this proposal (i) Drosophila oocytes,
where transport of microtubules by kinesin-1 drives bulk rotation of cytoplasm for localization of
polarity determinants and cytoplasmic dynein responsible for the bulk cargo transport in nurse
cells and from nurse cells to the oocyte; (ii) cells with elongated processes (neurons and terminal
cells of the trachea of Drosophila) where the movement of parallel or antiparallel microtubule
arrays is involved in the generation of processes and extension of the intracellular lumen in
terminal cells; (iii) dynamics of intermediate filaments in mammalian cells that is defined by
microtubules and microtubule motors. Discoveries of new mechanisms that we hope to generate
will be useful for development of new treatments of neurodegenerative disorders and the defects
of egg development in humans.

Public health relevance
PROJECT NARRATIVE We are studying the role of molecular motors in organization of the cytoskeleton and its dynamics using a several systems, including mammalian cultured cells and Drosophila tissues (ovaries, neurons, and trachea) in vivo and in vitro. We will address the question of how microtubules and motors define distribution of other components of the cell, how they perform the bulk transport of the cytoplasm and how the motors and microtubules transport intermediate filaments in mammalian cells. These data can be used for analysis of transport of molecular components in neurons, trachea, and female reproductive tract, while also providing an excellent experimental system to study fundamental questions in cell biology.